Sensing living P. aeruginosa using D-alanine derived radiotracers

PROJECT SUMMARY:
This application addresses a major challenge that radiologists and other physicians encounter frequently,
namely distinguishing active infection from other processes in the human body. Specifically, the proposed work
is motivated by the difficulty in diagnosing and treating pneumonias in cystic fibrosis patients, especially those
caused by P. aeruginosa. Clinically available imaging tools either (1) are limited by their background
accumulation in the lungs or (2) image the host response to infection rather than the living bacteria themselves.
To address this challenge, we have developed several PET radiotracers that exploit metabolic pathways
specific to bacteria, including D-amino acid derived probes most recently D-[3-11C]alanine.
When D-[3-11C]alanine was applied to several compelling preclinical models of infection, we found that it was
exquisitely sensitive to P. aeruginosa, which is not the case for the vast majority of reported radiotracers. We
further showed that D-[3-11C]alanine is a radiotracer with (1) a simple, high-yield radiosynthesis (2) good in vivo
stability (3) appropriate mimicry of the endogenous substrate (4) high rate of incorporation into both gram-
negative and gram-positive bacteria and (5) low uptake in background tissues. These studies demonstrate the
outstanding potential of D-[3-11C]alanine, with the proposed work necessary to further validate and understand
this tracer. We will first expand our radiochemical methods, synthesizing the D-[1-11C]alanine isotopomer and
structurally related 18F probes (Specific Aim 1). We will then further investigate the lead 11C isotopomer in
vitro, analyzing its performance in clinical P. aeruginosa strains and validated biofilm models (Specific Aim 2).
In Specific Aim 3, we will extend these concepts in vivo employing both acute and chronic models of P.
aeruginosa infection.

Public health relevance
PROJECT NARRATIVE: This proposal describes a new metabolic imaging technology to image infection, using a mirror-image amino acid that is an essential component of the bacterial cell wall. A new radiotracer developed for positron emission tomography will be used to identify bacteria common in cystic fibrosis patients with the goal of better understanding and treating this disease.